Development and Maintenance of Human and Animal Food Rapid Response Teams

Project Summary-Abstract for the Food Protection Rapid Response Team
The Missouri Department of Health and Senior Services (DHSS) has a long history of working
cooperatively with the Food and Drug Administration (FDA) on food safety issues and shares
the commitment to the development of an integrated food safety system.
There is a very diverse group of agencies, expertise, disciplines, capabilities and sources of
authority that protect our food supply, our citizens and the economic benefits of a safe food
supply. The Missouri Rapid Response Team (MRRT) combines those capabilities to respond
quickly, efficiently and effectively when an emergency threatens the food we eat. The MRRT
includes DHSS, FDA and the Missouri Department of Agriculture. The MRRT also has strong
partnerships and proven capabilities from different responses coupled with a commitment to
continuous improvement. The MRRT proposes to offer its expertise by continuing a rapid
center for subject matter experts who can help not only in Missouri, but also reach out as part of
a network to help the entire nation, while also searching for opportunities to create new subject
matter expert capabilities. Sharing expertise offers the opportunity to detect and stop
contamination sooner. Large foodborne outbreaks involve multiple jurisdictions. To meet that
challenge, the MRRT will continue to expand its outreach to the 115 local public health agencies
which include more educational opportunities, training and assistance in emergency response.
The MRRT will also maintain its work to incorporate lessons learned from responses and
exercises and use proven, measurable data to apply it to improved capabilities to strive for
continuous improvement.
In addition, Missouri will continue its work to keep a strong surveillance system so disease can
be detected quickly, while also striving to find and share information to prevent illness and
contamination. The MRRT will contribute information to other states and partners through a
variety of venues while also lending assistance and expertise to national efforts and workgroups
to improve and add to best practices and apprise the larger community about problems and
solutions in foodborne outbreaks and contamination.

Public health relevance
Project Narrative-RRT Foodborne illness and food contamination emergencies are complex and can stretch across many jurisdictions and multiple states. The Missouri Department of Health and Senior Services (MDHSS) proposes to not only maintain its Rapid Response Team (RRT) for food and feed to respond to large emergencies, but also to move ahead with improvements from lessons learned along with new innovations and initiatives. The Missouri RRT will add to its outreach in collaboration with local jurisdictions and other states, test and continue to apply new ideas to improve response capabilities, prevention and integration of the food safety system.